PENICILLIN G AND CEFTRIAZONE THERAPY OF NEUROSYPHILIS IN HIV POSITIVES--ACTG 145

A pilot study evaluating penicillin G and Ceftriazone as therapies for presumed neurosyphilis in HIV seropositive individuals.